Strategies for Engineering Reliable Value Sets (SERVS)

Project Summary/Abstract
Significant evidence suggests that CDS, when used effectively, can improve health care quality, safety,
and effectiveness. However, despite its potential, CDS can cause significant adverse events due to mal-
functions. In our previous work, we identified that a significant source of CDS malfunctions is related to
problems with maintaining accurate and consistent value sets. Value sets are “lists of codes and corre-
sponding terms, from NLM-hosted standard clinical vocabularies (such as SNOMED CT®, RxNorm,
LOINC® and others), that define clinical concepts.” They are commonly used in both clinical decision
support and clinical quality measures (CQMs) to define complex concepts. Creating and maintaining
value sets is inherently challenging, and value set errors can lead to errors in both CDS and quality
measurement. We have found that these errors are widespread and have a variety of causes. In the
MALDIVES (Machine Learning-Driven Interactive Value Set Enhancement System) project, we propose
the first comprehensive study of value set creation and maintenance, the development of novel and inno-
vative machine learning and ontology-based approaches for improving value sets, and the creation of
new, open-source tools to help value set authors and users. MALDIVES relies on a mix of qualitative
methods, development of novel ontology and machine learning-based methods for improvement of value
sets, and new open-source tools, and we anticipate that it will yield new theory, innovations in clinical ap-
plications of machine learning, and practical tools and processes for value set authors and users. These
advances will improve clinical decision support and quality measurement, reduce alert fatigue and con-
tribute to improvements in patient safety and healthcare quality.

Public health relevance
Project Narrative The proposed research is relevant to public health because it will develop tools to improve value sets, or lists of codes and corresponding terms from standard clinical vocabularies that define clinical concepts, which form the basis of many clinical decision support (CDS) and clinical quality measurement (CQM) systems (CDSS). CDS and CQMs have the potential to support providers in delivering safe and effective care, so improving the quality and accuracy of value sets will prevent errors in patient care from occur- ring and will contribute to the NLM’s mission pertaining to supporting health care and public health through research on biomedical methods, technologies, and utilization among health professionals.